URSODEOXYCHOLIC ACID TREATMENT OF PRIMARY BILIARY CIRRHOSIS

To compare the effects of ursodeoxycholic acid plus methotrexate versus ursodeoxycholic acid plus placebo on the course of patients with primary biliary cirrhosis.